Factors Affecting longterm in vitro culture of Treponema pallidum

ABSTRACT
Treponema pallidum subsp. pallidum is the causative agents of syphilis, a sexually transmitted infection with an
estimated worldwide incidence of 16-32 million new cases per year. The incidence of syphilis in the United States
has increased 6-fold over the past two decades. Although this important human pathogen was identified over
100 years ago, the inability to grow T. pallidum in vitro had greatly hampered research into its biology and
mechanisms of pathogenesis. In 2018, our group reported continuous long-term multiplication of T. pallidum in
co-culture with rabbit epithelial cells and a complex medium. We now have T. pallidum cultures that have been
maintained over five years. The in vitro cultivation system provides an excellent animal-free model system as
the in vitro cultured organisms fully retain “wild-type” motility, morphology, virulence and generation times.
Transcriptional profiles of T. pallidum grown in vitro are quite similar to organisms harvested from infected rabbits.
We have successfully used this in vitro culture system to isolate clonal populations of T. pallidum, to conduct
systematic nutritional analysis of nutrients required for growth in vitro, and to analyze patterns of peptidoglycan
synthesis and division sites. In recent studies, conditions have been identified that supported limited
multiplication of T. pallidum under axenic conditions (i.e. without the presence of mammalian cells). In the
continuation of this project, we propose to extend and expand the study of factors and genes affecting T. pallidum
multiplication using both metabolomic and mutational approaches. The specific aims are to 1) define T.
pallidum nutritional requirements and develop an empirically validated metabolic map with the goal of
achieving axenic growth; and 2) perform a global mutational analysis of T. pallidum genes involved in in
vitro growth and pathogenesis through transposon mutagenesis and other genetic approaches. The
further development of the T. pallidum in vitro culture system and the creation of a publicly available library of T.
pallidum mutants will likely facilitate many aspects of T. pallidum research, including studies of physiology,
structure, antimicrobial susceptibility, pathogenesis, and host immunity.

Public health relevance
NARRATIVE Although identified over 100 years ago, Treponema pallidum, the spiral-shaped bacterium that causes syphilis and related diseases, could not be grown in vitro, i.e. in a test tube, until 2018 when our laboratory achieved continuous in vitro multiplication of T. pallidum. The T. pallidum in vitro culture system is complex, including tissue culture cells, a specialized medium, and incubation under low concentrations of oxygen (1.5%), but appears to serve as an excellent replacement for the traditional method of growing T. pallidum in rabbits. In this project, we plan to optimize and simplify the culture system so that it can be used readily for research purposes, and we will also introduce mutations into the genes of T. pallidum to gain a better understanding of how the proteins they produce help this organism causes debilitating infections that can last for decades.